Heartland Cancer Research NCORP

DESCRIPTION (provided by applicant): The specific aims of the Heartland Cancer Research NCORP are to: (1)To be the primary vector for delivering; implementing, and executing NCI approved cancer treatment clinical trials to a large Midwestern rural and urban population; (2) To be the primary vector for delivering, implementing, and executing NCI approved cancer prevention, screening and control clinical trials to a large Midwestern rural and urban population; (3) To be the primary vector for delivering, implementing, and executing NCI approved Cancer Care Delivery Research clinical trials to a large Midwestern rural and urban population; (4) Enhance Midwestern cancer care by implementing a region-wide high standard of multidisciplinary integrated cancer care delivery; (5) Improve the education and outreach to all healthcare providers across rural and urban Illinois and Missouri regarding cancer clinical trials and incorporation of new research findings into daily patient care; (6) Improve cancer prevention, treatment, and survivorship education for healthcare professionals throughout Illinois and Missouri; (7) Perform breakthrough research in methods to improve the efficacy, efficiency, and cost effectiveness of cancer care delivery for a large region across Illinois and Missouri; (8) Reach out to underserved and vulnerable populations across Illinois and Missouri to improve access to cancer clinical trials, state of the art care, and cancer prevention and earl detection strategies; (9) Coordinate with local and state agencies to leverage resources to improve state wide cancer education regarding cancer prevention, early detection, treatment and clinical trials; (10) Continue to explore best practices for improving the productivity of Heartland NCORP within an environment of limited resources; (11) Continue to recruit, train, and support new investigators who share the vision and embrace the objectives of the Heartland NCORP

Public health relevance
PUBLIC HEALTH RELEVANCE: The Heartland Cancer Research NCORP (Heartland NCORP) will be the premier community cancer research organization of the states of Illinois and Missouri by providing state of the art cancer clinical trials, cancer care delivery research, interdisciplinary cancer treatment planning, and coordinated biomarker driven research throughout our service region.